Regulation and Function of SRF in Vascular Pathiobiology

There is now incontrovertible evidence that vascular smooth muscle cells (VSMCs) contribute substantively to
vascular diseases. The function or dysfunction of VSMCs is driven, in part, by the activity of key transcription
factors (TF). Serum response factor (SRF), an abundantly expressed TF in VSMCs that binds a large cadre of
CArG boxes colloquially known as the CArGome, orchestrates a number of disparate gene programs.
Surprisingly, almost nothing is known about the in vivo regulation of Srf transcription and, while the function of
SRF in vascular development is well understood, there is no information about its direct role in vascular
diseases; and gender-based studies are not possible given the limitation of the most popular SMC Cre driver
(Myh11). Moreover, the full complement of SRF target genes (notably long noncoding RNAs, lncRNAs) is not
known. We have been a leading lab in SRF research and now offer fresh insights into these major scientific
gaps that, collectively, form the basis of this application. First, we provide CRISPR-Cas9 genome editing
results, bioinformatic predictions, ChIP-seq, and luciferase data supporting functional transcription factor bind-
ing sites (TFBS) controlling Srf transcription in vivo. Second, gene expression and Srf loss-of-function (LOF)
studies support SRF as an early mediator of VSMC growth, inflammation, and neointimal formation following
acute vascular insult. Importantly, existing Cre driver mice limit analysis of Srf LOF to a narrow time window of
only 10-14 days post-tamoxifen due to a competing, lethal phenotype of the gastrointestinal (GI) tract. How-
ever, we have recently generated and validated a new Cre driver mouse with restricted Cre-mediated excision
to VSMCs; little activity is observed in visceral SMCs of the GI tract, and a cross with floxed Srf mice shows
extended survival providing the first ever opportunity to interrogate the function of SRF in both acute and
chronic models of vascular disease without confounding phenotypes. Finally, genomic studies implicate a new
SRF-dependent VSMC inflammatory gene program and CRISPR studies show a specific base substitution
within the CArG box nullifies SRF-dependent gene expression in vivo. Three integrated aims will rigorously test
the hypothesis that multiple TFBS control Srf expression to direct CArG-dependent homeostatic or
pathogenic gene programs in the vessel wall. Aim 1 will evaluate the function of new TFBS governing Srf
transcription using CRISPR editing in the mouse. Aim 2 will elucidate phenotypes associated with Srf LOF and
gain-of-function in acute and chronic models of vascular disease using a novel Cre driver mouse for
unparalleled VSMC specificity. Aim 3 will further utilize mice in Aim 2 for integrative VSMC ChIP-seq and RNA-
seq studies to elucidate novel SRF target genes, particularly the class of lncRNAs, in the control of VSMC
phenotypes; CRISPR editing of key CArG boxes are planned as a new paradigm to study gene function. These
studies will vertically advance our knowledge of SRF regulation and function, paving the way towards new
therapeutic approaches to combat vascular diseases while advancing new directives for further research.

Public health relevance
Vascular disease is accompanied by changes in gene expression. SRF binds CArG boxes to direct normal or abnormal gene expression in cells of the vessel wall called smooth muscle cells. We will use novel tools in genetics and genomics to define, for the first time, the role of SRF in acute and chronic models of vascular disease. Findings will inform future therapeutic strategies to combat human vascular diseases.